Project 2: Revealing Viral Population and Host Environment Dynamics of SIV Tissue Reservoir

PROJECT SUMMARY/ABSTRACT
Despite the remarkable success of the combination antiretroviral therapy (cART) to control HIV-1 infection, viral
reservoirs persist indefinitely under treatment. These remaining viral populations constitute the principal burden
for an effective HIV-1 cure, as they lead to a rapid rebound in viremia when treatment fails or after analytic
treatment interruption (ATI). Unfortunately, our understanding of the mechanisms of HIV-1 persistence during
cART is limited because the viral reservoir population size is very small and it is established within a wide variety
of susceptible tissues, inaccessible to evaluation. Hence these difficulties, the majority of the reservoir studies
do not include tissue samples or study a very limited sampling of the tissue reservoirs. Therefore, we are not
able to properly study these viral populations and their main characteristics remain unknown. Understanding the
nature and properties of these tissue reservoirs during treatment is key to design a successful HIV-1 cure
strategy. The team comprised by the Hope lab and Dr. Villinger has optimized and refined their 89Zr-labelled
FAB2 probe that allows for the in vivo detection of cells expressing SIV env in an infected macaque. Using this
approach, they have generated a new PET-CT-based workflow for the identification and downstream
characterization of foci of SIV infection in tissues. This updated “beacon-guided system” is exquisitely sensitive
and it is extremely powerful to find and characterize small foci of infected cells during cART or early after ATI,
prior to any detectable viremia. These foci represent extremely rare events that are key to the understanding of
underlying SIV biology and yet, to date, were only found through random and/or biased survey of tissue. In the
current proposal, we intend to use the Hope lab ability to localize SIV active viremia sites in infected macaques
and complementary genomic analysis workflows optimized by our team, to perform in-depth spatio-temporal
studies of the reservoir viral population dynamics. We will use phylogenetic, evolutionary, and phyloanatomy
analysis to study the characteristics tissue reservoirs. We will also assess the contribution of biological processes
such as clonal expansion, residual viral replication, and viral production bursts in the process of reservoir
persistence during cART. Additionally, we will analyze the characteristics and transcriptional profiles of the
different cell types that harbor the reservoir in tissues using our multiple complementary genomic techniques.
We will use PET-CT-guided RNAseq and PET-CT-guided spatial transcriptomics from SIV positive tissues, and
isolate specific types of infected cells to analyze their transcriptional profiles using single-cell analysis. Due to
Hope lab’s findings indicating that mast cells could be key in the reservoir persistence, we plan to specifically
study the role of these mast cells in the viral population dynamics of the tissue reservoirs. By following this
multidimensional approach, we will define with unprecedented detail the main properties of the cells in tissues
that harbor the reservoir during treatment and are the initial source of the rebounding virus when treatment is
interrupted.